Endometrial Cancer Survival and Survivorship among Latinas in California: A Mixed Methods Study

PROJECT SUMMARY/ABSTRACT
The goal of this F31 fellowship is to prepare me to become an independent researcher who can effectively
contribute to addressing cancer disparities for Latina women with endometrial cancer (EC). EC is the third
most prevalent cancer among Latina women, representing 8% of all new cancer diagnoses among Latinas in
the United States. Higher than any other racial/ethnic group, Latinas have had a 30.2% increase in EC
incidence between 2010 and 2017. EC is the second most common cancer survivor site among women of all
race/ethnicities. While Latinas with EC have relatively high 5-year survival rates, they also are more likely to be
diagnosed with later stage and more aggressive disease, have lower quality of and barriers to equitable cancer
treatment and follow-up care, and have lower levels of income, education, and health insurance compared to
white women. Further, their interactions with the healthcare system and socio-ecological contexts in which they
live can directly shape opportunities for and barriers to optimal health impacting their survival and survivorship.
Under the guidance of my mentorship team and enhanced by the training from this fellowship, I will conduct an
explanatory sequential mixed methods study to examine how macro/systemic level contexts shape the EC
survival outcomes and survivorship experiences of Latinas. The Specific Aims of this study are to: 1) Examine
the association between treatment facility and endometrial cancer survival and to explore whether
race/ethnicity moderates this association; 2) Investigate the association between neighborhood socioeconomic
status and EC survival and to examine whether race/ethnicity moderates this association; and 3) Qualitatively
explore and characterize Latina EC survivors’ lived experiences and the impact of healthcare system and
socio-ecological contexts on survivorship. To accomplish the proposed research, I will implement a
comprehensive training and mentorship plan that will build upon my prior cancer health disparities knowledge,
research experience, and doctoral training. Specifically, my Training Goals will focus on expanding my
knowledge and skills in: 1) cancer epidemiology for gynecologic cancers and gynecologic oncology treatment
and survivorship practices; 2) cancer disparities across the cancer continuum; 3) intersections of race/ethnicity,
socioeconomic position, and gender with inequities in health, with a focus on Latino and immigrant
communities; 4) mixed-methods research approaches and interpretation; 4a) quantitative methodology
including epidemiologic methods, survival analysis, and multilevel modeling; 4b) qualitative methodology; and
5) grant writing. These goals will be accomplished through a range of coursework, seminars/workshops,
clinical exposure, conferences, journal readings, and tailored mentoring from a committed team of
interdisciplinary researchers. Complemented by support from a dedicated research and training environment at
the University of California, Irvine Program in Public Health, this fellowship will accelerate my trajectory in
becoming an independent researcher focused on reducing cancer disparities in gynecologic cancer.

Public health relevance
PROJECT NARRATIVE The goal of this research is to further our understanding of endometrial cancer survival outcomes and survivorship experiences for Latina women through an exploratory sequential mixed methods approach. This study will have a positive impact on cancer disparities research by advancing the knowledge of the macro/systemic level contexts that influence and shape endometrial cancer survival outcomes and survivorship experiences among Latina women. Findings from this research will help to inform public health research and practice interventions to improve survivorship experiences and will set up future research inquiries to further examine endometrial cancer survival and survivorship among Latina women.